Development and Pilot of a Parent Based Intervention for Reducing High-risk Social Networking Site Cognitions, Alcohol Use, and Negative Consequences Among Adolescents

PROJECT SUMMARY/ABSTRACT
The prevalence of underage alcohol use continues to be a public health concern. Numerous studies have
reported associations between teen drinking tendencies and parental attitudes and beliefs, parental awareness
of teen drinking, parental monitoring and the quality of the parent–teen relationship and communication. The
extensive work in this area has resulted in parent-based intervention (PBI) efforts to prevent or reduce
adolescent alcohol use. Several independent studies have indicated that teens whose parents received a PBI
reported less alcohol use and fewer alcohol-related consequences. Despite these strengths, one major
limitation of PBI is that they do not currently take into account the large role that social networking sites (SNS)
use plays in adolescents’ lives and in relation to their alcohol use. Most (90%) adolescents are on SNS, and
their Facebook, Instagram, and Twitter profiles include alcohol content. As such, we propose to develop and
refine an interactive PBI designed to reduce high-risk SNS cognitions (i.e. attitudes and norms), alcohol use,
and negative consequences among adolescents. To achieve study aims, we propose an iterative process of
online focus groups in order to develop and refine the interactive PBI to be delivered in the pilot study with 1
and 6 month follow-up among 100 parent/teen dyads. The objective of this R34 application is to establish
feasibility and acceptability of the newly developed interactive PBI that focuses on the role of SNS in
adolescent alcohol use as well as to determine preliminary effect sizes for future studies. This administrative
supplement (PA-20-272) request is being submitted to meet increased costs that are within the scope of the
approved award but were unforeseen due to COVID-19. Specifically, the proposed supplement will allow us to
maximize the remaining time in our original timeline to finish developing and launch the Phase 2 pilot study in
late Fall 2021. With the COVID-19 pandemic, there was a delay in launching Phase 1 Focus Groups due to
restrictions on in-person research at our institution. As such, we needed to pivot the project to be delivered
completely online. As a result, we experienced increased programming costs and a delay in timeline based on
this change in focus group format and the necessary human subjects approvals and processes at our
institution. Further, without the ability to do many of our routine in-person recruitment strategies (e.g., such as
going to schools, community events, and handing out flyers in person) based on university and community
guidelines and precautions, we have spent and anticipate needing to continue to spend more money on online
advertising alternatives (social media, online newspapers) than originally expected. Finally, because of the
delay in project timeline we are currently understaffed to sufficiently meet our study aims and to successfully
carry out the remainder of the project. Thus, in order to achieve these goals, we will need additional faculty and
staff effort and increased advertising and programming costs as requested in this supplement.

Public health relevance
PROJECT NARRATIVE The central goal of this application is to develop and pilot an interactive parent-based intervention (PBI) aimed at reducing high-risk social networking site cognitions, alcohol use, and negative consequences among adolescents. This aim will be achieved by conducting online focus groups for parents and teens and a pilot study with randomization to an interactive PBI or active control with 1 and 6 month follow-up surveys among 100 parent/teen dyads. This administrative supplement request is being submitted to meet increased programming, advertising, and staffing costs that are within the scope of the approved award but were unforeseen due to COVID-19.